Discriminating hormonal and sex chromosomal origins of sex differences in the septohippocampal circuit

PROJECT SUMMARY
Depression is sex biased not only in its rate, but also in precipitating factors and symptoms. For example,
women report a lack of social support, while men report stressful events as major contributors to depression.
Understanding the mechanisms that drive these sex differences involves isolating different molecular pathways
to identify the causes of divergent vulnerability and symptoms. Sex chromosomes (XX vs. XY) are a major
source of sex bias within any type of cell, but this category has been difficult to discriminate from gonadal
hormone effects that often co-vary with sex chromosome complement. Sex chromosome effects on disease
mechanisms can now be studied in newly engineered XX and XY rats that have the same type of gonad, either
with testes or with ovaries. In these Four Core Genotypes (FCG)-like rats, sex chromosome effects (XX vs. XY)
will be discriminated from gonadal hormone effects that differentiate the brains of gonadal males from those of
gonadal females. Here we focus on the origins of sex differences in the septohippocampal circuit, which
consists of the medial septum (MS) projection to the hippocampus. The septohippocampal circuit mediates
memory and its dysregulation is implicated in the cognitive deficits that characterize several disorders,
including depression. We previously found that administering the stress neuropeptide, corticotropin releasing
factor (CRF), into the MS impairs hippocampal-dependent object location memory in rats. However, males are
more sensitive to this effect than females. Ovarian hormones do not confer resilience in females, and structural
sex differences in the MS of mice are causes by sex chromosome effects (SCEs). We aim to discriminate
SCEs from gonadal hormone effects that cause sex differences in the septohippocampal circuit that mediates
cognitive deficits in major depression, and to understand where these factors act and what molecular
mechanisms they control. Aim 1 will use the FCG-like rats to test the hypothesis that sex differences in CRF
receptor regulation of MS-mediated memory are due to SCEs. The beauty of the design is that even if the
hypothesis is not supported, the origin of sex difference in this stress effect on memory will be identified. To
determine molecular mechanisms that can underlie sex differences in the septohippocampal circuit, Aim 2 will
use single-cell RNAseq to differentiate neuronal and glial subtypes of the MS and hippocampus, identify sex
differences therein, and determine whether sex differences are caused by SCEs or gonadal hormones. Cell-
cell communications will be modeled within and between cell types and brain regions to retrieve cellular circuits
affected by SCEs vs. gonadal hormones. Collectively, the integration of sophisticated behavioral and molecular
analysis will uncover cell-specific mechanisms by which diverse sex-biasing factors influence stress regulation
of memory. These results will have important implications for developing novel treatments for depression that
work well in males and females.

Public health relevance
Narrative Stress exacerbates cognitive deficits in major depression, a disorder that is sex biased and linked to the stress hormone corticotropin releasing factor (CRF). The current project uses novel genetically modified rats to discriminate between effects of hormonal and sex chromosomal factors that cause sex differences in the brain. Sex differences will be studied at the behavioral and molecular levels in circuits where CRF regulates memory.